Immunosuppressive Neutrophils Modulate Alloimmune Responses After Lung Transplantation

Project Summary/Abstract
This proposal outlines a 5-year research and career development plan to support Dr. Amit Bery’s transition to
independence as a physician-scientist studying how innate immune cells affect adaptive immunity after lung
transplantation. The proposed research project, which focuses on how interleukin-1β (IL-1β) promotes the
differentiation, release, and trafficking of immunosuppressive neutrophils that downregulate
alloimmune responses after lung transplantation, will take advantage of clinical and scientific expertise and
unique resources available at Washington University School of Medicine. The proposed career development and
training plan will strengthen Dr. Bery’s fund of knowledge and develop important skills in bioinformatics and
advanced imaging techniques that will promote his successful transition to independence.
Dr. Bery has generated preliminary data showing that recipients deficient IL-1β uniformly reject pulmonary
allografts. These preliminary data show that IL-1β signaling is necessary for G-CSF release which results in an
intragraft neutrophilia that is abrogated in IL-1β-deficient recipients. Dr. Bery has also shown that these graft
infiltrating neutrophils express markers associated with an immunosuppressive phenotype and that these
neutrophils can suppress T cell responses in vitro. The short-term goals of this proposal include evaluating
mechanisms how IL-1β signaling induces the differentiation and release of these neutrophils from the bone
marrow (Aim 1), and to define trafficking requirements that promote the homing of these neutrophils to pulmonary
allografts (Aim 2). He will utilize the techniques of flow cytometry, histopathology, in vitro colony forming cell
assays, and advanced downstream analyses of single cell RNA sequencing data (Aim 1) along with in vitro
transmigration assays, flow cytometry, histopathology, and real-time intravital 2-photon imaging (Aim 2) to
achieve these short-term goals.
The long-term goal of this work is to develop immunosuppressive strategies that are tailored to the lung. While
outcomes after lung transplantation rank the worst among all transplanted solid organs, immunosuppressive
strategies for recipients of pulmonary allografts have been derived from studies in other organs, mainly kidney
transplantation. Thus, there is a major need to identify lung-specific immunosuppressive strategies to improve
the longevity of pulmonary allografts and overall survival after lung transplantation. As many lung transplant
candidates and nearly all lung transplant recipients are treated with immunosuppressives that may limit their
ability to mount an emergency myelopoietic response to transplantation, the proposed work carries the potential
to influence how immunosuppression is utilized after lung transplantation and may provide new insights on the
effects of therapies for lung transplant candidates on the waitlist.

Public health relevance
Project Narrative Despite medical and surgical advances over the last 30 years, outcomes after human lung transplantation remain the worst among all transplanted solid organs with median survival less than 7 years. The proposed research aims to identify mechanisms important to the acceptance of pulmonary allografts which will contribute to fundamental knowledge about the nature and behavior of alloimmune responses and allow the development of lung-specific immunosuppressive strategies to prolong graft and overall survival after human lung transplantation. Completion of the research, training, and mentoring plans outlined in this proposal will directly contribute to my independence as a physician-scientist and allow me to develop a research program that will aim to improve the longevity of pulmonary allografts and improve survival of human lung transplant recipients.